BMP Signaling Promotes Immune Cell Differentiation in Human Intestinal Organoids

Project Abstract
Human pluripotent stem cell (hPSC) derived human intestinal organoids (HIOs) are a powerful model since
they possess many lineages, including epithelium, smooth muscle, neurons, and endothelial cells; however,
HIOs lack immune populations, which are key to studying the development and maturation of the intestine.
Since early HIOs possess mesoderm, I tested the hypothesis that this population may respond to cues, such
as BMP signaling, that induce immune cell differentiation. Preliminary data supports a role for BMP signaling
as an inductive cue for CD45+ immune cells within small intestinal HIOs. This proposal will test the hypothesis
that early HIOs retain plasticity soon after intestinal patterning and have mesenchyme-specific responses to
BMP signaling, which leads to differentiation of the mesenchyme into hemogenic endothelium that will further
differentiate into functional immune lineages. I aim to interrogate the mechanism by which BMP4 induces
immune-like cells, through a hemogenic endothelium intermediate, in HIOs, including the cell intermediates
required for immune cell differentiation. Secondly, I aim to investigate the lineages of immune cells present and
functionally evaluate the immune-like cells in the HIOs.

Public health relevance
Project Narrative Dysregulation of the immune system in the intestine has been linked to many diseases, such as Inflammatory Bowel Disease, Celiac Disease, and Necrotizing Enterocolitis. Most human model systems, including organoids, are not primed to investigate these diseases as they lack the immune component necessary to recapitulate the inflammation that drives the pathophysiologic changes in vivo. The goal of this proposal is to interrogate the complex signaling environment that leads to early immune cell differentiation in the intestine, using complex stem cell derived human intestinal organoids as a model that can ultimately be implemented to interrogate inflammation based intestinal pathologies such as necrotizing enterocolitis or inflammatory bowel diseases.